Modeling the Responsiveness of Sensitive Populations to Genotoxic Agents Using DNA Repair Inhibitors

Project Summary
It is well recognized that conventional toxicology assays exhibit two crucial deficiencies. First, the use of limited
numbers of cell lines and laboratory animal models/strains does not provide information about the degree to
which a particular chemical may exhibit highly variable potencies across exposed humans. Although studying
very large numbers of cell lines and laboratory rodent models could theoretically address this issue, it is not a
practical answer. There are simply too many legacy chemicals and new chemical substances being developed
for this to represent a routine testing scheme. A second issue with the current schema is that it does not
typically generate much information regarding the molecular mechanism(s) responsible for a toxic effect.
Fortunately, in the area of genetic toxicology, a solution exists for both of these issues. Our innovative
approach takes into account the fact that inter-subject differences in sensitivity to genotoxic agents is often
driven by variable DNA repair capacity. Our solution is based on a single p53-competent human cell line (TK6).
Whereas test chemical-exposed TK6 cells will be used to generate reference responses, we will model
sensitive subpopulation responses by co-exposing cells to each test chemical in combination with a panel of
small molecule DNA repair inhibitors. These inhibitors will be chosen to cover each of the major DNA repair
pathways. This platform will simultaneously allow us to identify for further testing those chemicals that are most
likely to exhibit the greatest variation in genotoxic potency across exposed humans, and also provide insights
into genotoxic mechanism. Innovative aspects of our project include our use of an automated, multiplexed DNA
damage assay to cover multiple biomarkers of genotoxicity and cytotoxicity, and state-of-the-art benchmark
dose software to characterize the family of dose-response relationships that will be generated for each
chemical studied. Once reduced to practice, we will make the assay available through fee-for-service chemical
testing, with an eventual goal of selling reagent-containing kits.

Public health relevance
Project Narrative Conventional toxicology testing relies on small numbers of cell lines and laboratory animal models/strains. This paradigm has two serious deficiencies—it does not provide information about how much more sensitive certain humans may be to a particular toxicant’s deleterious effects, and does not typically provide insights into molecular mechanisms responsible for the adverse effects. The goal of our project is to develop a cost- effective, high throughput in vitro human cell-based assay that: i) prioritizes for further testing those chemicals that are most likely to exhibit the greatest variation in (geno)toxic potency across exposed humans, and ii) provides insights into genotoxic chemicals’ molecular mechanisms. Once reduced to practice, we will make the assay available through fee-for-service chemical testing, with an eventual goal of selling reagent-containing kits.